Using co-evolution to understand the emergence of bacterial phenotype from proteome variation

Project Summary/Abstract: A fundamental problem in biology is to understand how the compendium of
proteins in an organism (the ‘proteome’) cooperatively interact to create phenotype. Despite considerable
experimental and computational advances with respect to defining and inferring protein-protein interactions
(PPIs), no method currently exists to infer a hierarchy of protein interactions: that is, how proteins interact to
create complexes, pathways, and phenotype. This proposal uses bacteria as a model to develop a novel
statistical method that transforms a genome sequence into a hierarchy of protein interaction networks. Key to
this approach is the advance that components of variation typically discarded as noise (harboring < 0.01%
variance) in fact do contain biologically important information regarding PPIs. Preliminary results illustrate that
our statistical method may be an effective multi-scale framework to describe emergent biological function
arising from a ‘parts-list’ of proteins. We call our approach Spectral Correlation Analysis of Layered
Evolutionary Signals (SCALES); the main thrust of our proposal is testing the experimental validity and
robustness of our approach. With respect to validity, we will combine high-throughput molecular genetics with
computation to test whether SCALES can accurately infer functions of uncharacterized proteins using P.
aeruginosa as a model system. With respect to robustness, we will test whether our results are robust to the
genomic feature used for measuring co-variation.
Looking to the future of the laboratory, SCALES may be generally useful for understanding hierarchical
architectures across different biological systems, spanning proteins to cells to ecosystems. Therefore, we
believe this proposal will serve as a critical launching point to explore important concepts central to the focus of
the post-genomic era, namely creating novel mathematical frameworks by which to convert the torrent of high-
content, complex data being collected into useful and actionable biological knowledge.
For defining the vision of the laboratory, natural systems are products of a generative process that is
poorly understood—the evolutionary process. Though properly described as random variation and selection,
evolution generates remarkably ordered, low-entropy biological systems that execute high-performance
functions, are robust to perturbation, and have the capacity to adapt to new functions. It is therefore
conceivable that quantitatively understanding design architectures of evolved systems, and how they come to
be, may yield a new theoretical foundation of engineering for systems with natural-like properties; namely, the
ability to dynamically interact with the environment. The broad vision of the Raman Lab is to elucidate
organizational principles that govern the ability of evolved systems to work as well as maintain fitness. We
hope to address this problem in a variety of systems subject to component variation and environmental
selection. In doing so, our ultimate hope is to create rubrics for designing adaptive systems intelligently.

Public health relevance
Project Narrative Despite substantial advances in our ability to collect genomic data and catalog genetic variation, understanding how the collection of proteins in an organism create phenotype is difficult to determine because phenotype emerges from a hierarchy of protein interactions: proteins interact to create complexes, pathways, and phenotypes. To date, no method exists to elucidate a hierarchy of protein interactions. Using bacteria as a model, this proposal seeks to develop and validate a novel statistical approach that defines hierarchically layered networks of protein interactions that describe the emergence of complex phenotype from a `parts-list' of proteins from genome sequence alone. In the emerging era of `big-data' in biology, such an approach substantially aid in relating genotype with cellular behavior, and may be a generally effective framework towards parsing high-content, complex biological data.